The Effect of Pesticide Exposure on Cognitive and Brain Development in Latino Children: PACE5 Administrative Supplement

The primary objective of this administrative supplement proposal is to transform the way dynamic functional brain network data is visualized, interpreted, and shared. There is a growing literature demonstrating the power of brain network analyses with more recent studies using dynamic brain network analyses to assess brain network changes over time. To generate functional brain networks, functional magnetic resonance (fMRI) data are processed to identify brain regions that are functionally connected. Dynamic brain network analyses yield ~ 200 brain networks for each study participant. These analyses result in extremely large datasets that are difficult to manage, visualize, and combine across studies. We propose to develop the methodology necessary to map dynamic brain network data into a standard 2-dimensional (2D) space to generate dynamic functional trajectories. An algorithm to map dynamic brain networks to this standard pace will be shared across brain imaging research studies. Data can then be viewed and interpreted in a consistent manner across studies allowing for direct comparison (including quantitative assessments) of results. This supplement is associated with the parent project “Preventing Agricultural Chemical Exposure 5 (PACE5)” that is examining the effects of pesticide exposure on children of Latino farmworkers. The parent project will be collecting functional brain imaging, cognitive, and pesticide exposure data on 8-year old children at baseline and will follow the children for 2 years. Dynamic functional brain networks will be used to identify association with pesticide exposure and neurocognitive development. Ultimately this supplement will enhance data sharing across dynamic functional brain network studies and will enable us to combine data from the parent study of brain development in Latino children with data from existing databases and from ongoing or future studies examining the effects of environment exposure on brain development. The specific aims of this supplement are: Aim 1: Develop an algorithm that will allow for embedding high-dimensional dynamic brain networks in 2- Aim 2: Evaluate and demonstrate the utility of dynamic trajectory comparisons across studies by combing data from our prior PACE study and the Human Connectome Project (HPC). To enable the scientific community to use these new methods, the algorithms for generating dynamic trajectories in standard space will be made openly available. The software and documentation will be deposited in NITRC (https://www.nitrc.org/). Dynamic trajectories from our study will be made available for integration with other research projects. The new methodology will increase the overall value of our study by allowing us to readily share our data with other investigators and integrate data from other studies into our analysis and interpretation.

Public health relevance
This administrative supplement will develop methods to standardize the data structure for dynamic functional brain network data. The methods will be made openly available to the scientific community to enhance data sharing across studies.